Machine learning approaches towards risk assessment and prediction of adverse pregnancy outcomes

PROJECT SUMMARY
The primary objectives of this project include understanding the interplay between molecular, genetic
and clinical factors related to adverse pregnancy outcomes (APOs), method development for accurate
risk assessment of APOs well before they occur, and method development for collecting additional
clinical data in routine treatment of at-risk-subjects. Towards these goals we have assembled a team of
investigators with clinical, translational, and computational expertise capable of identifying novel
contributors to APOs as well as facilitating clinician-patient interactions using data-driven and
theoretically sound machine learning approaches. Our strategies will rely on advanced machine
learning as well as integration of clinical, genetic, and molecular data and hold promise to bring
precision medicine to the treatment and experience of women during and post pregnancy. We will
predominantly rely on the data collected during the national “Nulliparous Pregnancy Outcomes Study:
monitoring mothers-to-be”; i.e., the nuMoM2b study. Using the cohort of 10,038 nulliparous women, we
will efficiently accomplish 3 Aims: to integrate genetic, clinical, and molecular features towards a deep
understanding of APOs; to develop machine learning models for advanced risk prediction; and to
engage in active data collection towards risk assessment and model development. Using a close
collaboration between computational and clinical scientists, we believe this proposal will result in
important advances in understanding the molecular and clinical aspects of APOs as well as assessing
the risk for APOs and thus providing tangible contributions to maternal health.

Public health relevance
PROJECT NARRATIVE Utilizing advanced machine learning as well as integration of clinical, genetic, and molecular data, this proposal seeks tangible advances in individualized risk prediction for adverse pregnancy outcomes. This research is relevant to public health in that it will provide mechanistic insights and opportunities for personalized prevention strategies for avoiding adverse pregnancy outcomes.